Research Study to Assess the Risk of Blood-Borne Transmission of Classic Forms of Creutzfeldt-Jakob Disease

Project Summary
Creutzfeldt-Jakob disease (CJD) is a rare, fatal, neurodegenerative disorder caused by
abnormal prion agents. Transmissibility of the non-variant (sporadic, familial, iatrogenic) forms
of CJD by blood transfusion is currently unknown, while variant CJD (vCJD) has been
transmitted by blood transfusion. The proposed project will continue the only active nationwide
look-back study on recipients of blood products from donors subsequently diagnosed with CJD.
This study began in 1995 and has been working for the past 24 years on the key objective of
carefully and systematically assessing the risk of blood borne transmission of this disease in the
United States. The major components of the study include collaboration with multiple sources to
identify blood donors diagnosed with CJD in the United States; working with blood centers to
trace the blood components from these donors to final disposition; collecting vital status and
cause of death information (if applicable) on the recipients of these blood components; utilizing
the data from the study to continually monitor and assess the risk of blood-borne transmission of
CJD; and disseminating results of the study to relevant stakeholders.
To date, the study has enrolled 76 blood donors who died of CJD and 1,000 recipients of
their blood. Through 2016, 211 of these recipients were presumed to be still alive and 789 were
deceased. Following transfusion, these two groups have survived a total of 4898 person-years. A
total of 337 recipients survived five years or longer post transfusion and 125 of them had
received blood donated 60 or fewer months before the onset of CJD in the donor. No recipients
with CJD have been identified.
The current results of this large, ongoing lookback study show no evidence of transfusion
transmission of CJD. They reinforce the conclusion that the risk, if any, of transfusion
transmission of prion disease by CJD donors is significantly lower than the comparable risk of
such transmission by vCJD donors.

Public health relevance
Project Narrative This study collects blood recipient outcome data to assess the potential risk of transmission of classic Creutzfeldt-Jakob disease (CJD) by blood components from donors who subsequently developed CJD. There are two phases to this study, retrospective and prospective. The retrospective phase identifies the CJD diagnosed blood donors and the recipients of those blood components while the prospective phase that tracks these recipients for the development of CJD. During the retrospective phase, we receive reports about blood donors who subsequently developed CJD from blood centers, family members, physicians and the National Prion Disease Pathology Surveillance Center. Once we receive the report, we obtain consent from the donor’s family if they reported to us directly and seek to verify the donor’s CJD diagnosis through autopsy report or neurologic confirmation, if available. We then notify the blood center (if previously not notified) and they contact the consignees of the blood components. The consignees identify the recipients and report the personal identifiers, vital status and if deceased the date and cause of death of that recipient. If the recipient is listed as deceased, we verify the date and cause of death with the National Death Index (NDI) using the reported information. If the recipient is listed as alive we move onto the prospective phase of the study. This consists of tracking the recipient to see if they are currently alive (as of the last available NDI dataset) and if not, document the date and cause of death. We track the recipients by using the NDI Plus database and other databases (e.g., Ancestry.com, LexisNexis) as needed. We match the consignee-provided recipient information to the information in the database(s) to determine if it is a match. The risk to the human subjects is minimal. For donors who are reported by the blood centers, only the donor initials are available to us. For those individuals whose family members report the case, the family receives an information letter and Consent for Participation and Release of Information form to fill out. Investigation does not proceed unless the consent for participation is signed. Only the donor initials are used when inputting the data in the database. The risk is also minimal for the recipients. The surviving recipients are not notified of the tracking because to date there has not been a case of transfusion-transmitted non-variant CJD. Notifying the recipient would cause undue stress because there are currently no diagnostic tests or treatments available. All recipient information is kept in a secure cabinet with very limited personnel access. The name, date of birth and Social Security number of the recipients are recorded in the password protected database on the secure Red Cross server and the can only be accessed by project staff.